Contribution of Medullary Pre-Sympathetic Neurons on the Progression of Breathing Disorders and Autonomic Dysfunction in Heart Failure with Preserved Ejection Fraction

PROJECT SUMMARY
Heart failure with preserved ejection fraction (HFpEF) is a public health problem affecting more than 26 million
people worldwide. Currently, there are no effective strategies for managing HFpEF and projections indicate that
its prevalence will double by the next decade. In the past years, we have been able to provide compelling
evidence to support the pivotal role played by pre-sympathetic neurons located in the ventral aspect of the
medulla (RVLM-C1) on experimental HFpEF pathophysiology, by orchestrating autonomic, cardiac, and
respiratory failure during disease progression, since their selective ablation reduces sympathetic activity and
arrhythmogenesis, restored normal respiratory function and improve cardiac diastolic function in rodents with
HFpEF. Accordingly, knowing the therapeutic window to target RVLM-C1 neurons during HFpEF progression
may offer salutary potential to improve HFpEF outcomes. Then, having the ability to create neuronal activity
maps from the RVLM during HFpEF progression along with cardiorespiratory physiological monitoring should
generate precious data for the development of diagnostic and therapeutic tools in the setting of HFpEF.
Therefore, our primary aim will be to provide, for the first time, RVLM-C1 neuronal activity mapping in-vivo and
in-vitro, during the early, mid- and long-term experimental HFpEF in combination with longitudinal
cardiorespiratory and cardiac function monitoring. Obtaining all this physiological information in the setting of
HFpEF will deliver comprehensive evidence about the precise changes in the neural control of hemodynamic
and respiratory function serving to design therapeutic interventions during each HFpEF stage. In addition, our
secondary aim will be to perform an un-precedented molecular characterization at both the transcriptomic and
metabolomic level of the changes involved in RVLM-C1 neuron aberrant activity in HFpEF. Finally, we will test
whether FDA-approved sympatholytics applied within a defined therapeutic window (i.e. at the onset of RVLM
hyperactivation) offers salutary potential in cardiorespiratory outcomes in experimental HFpEF. Altogether, our
results should provide compelling information about precise timing for the alterations in the neural control of
cardiorespiratory function in HFpEF uncovering potentially relevant therapeutic windows for the treatment of the
neural origin of autonomic and breathing disorders.

Public health relevance
PROJECT NARRATIVE Heart failure with preserved ejection fraction (HFpEF) is a worldwide health problem affecting more than 26 million people. Heightened sympathetic nervous system (SNS) activity and disordered breathing are both considered hallmarks of HFpEF and are closely linked to disease morbidity and mortality. In this project, we expect to define, for the first time, a therapeutic window in which targeting central pre-sympathetic neurons in experimental HFpEF offer salutary potential to improve cardiovascular and respiratory outcomes.